Evaluating the ELF5 Clock as a Biomarker in Breast Cancer Prevention Trials

Breast cancer is the most prevalent cancer among women in the United States, with projections indicating a
substantial increase in newly diagnosed cases by 2040, largely due to the aging population. Prevention
emerges as a viable strategy to curb this rise. A major challenge in breast cancer prevention clinical trial
design is a dearth of biomarkers predictive of risk reduction. Indeed, there is an urgent need to develop
biomarkers capable of detecting the biological effects of interventions, facilitating a more accurate assessment
of their effectiveness. Aging is the greatest risk factor for breast cancer. We have proposed that understanding
the mechanisms by which age increases susceptibility to breast cancer is crucial for developing a prevention
strategy. We showed that the loss of lineage fidelity in luminal epithelial cells is a striking hallmark of aging,
and of overall increased susceptibility, in breast. This is significant because luminal cells are thought to be the
cell-of-origin for most breast cancers. Among the most prominent molecular changes in the loss of lineage
fidelity is the downregulation of ELF5, a transcription factor crucial for maintaining young and healthy luminal
cell states. Based on age-associated expression of ELF5, we developed an “ELF5 clock” that measures
biological age in breast tissue, identifying women who are at high risk regardless of the specific monogenic trait
or aging risk factors. Furthermore, we showed that ELF5 expression once lost can be regained in conditions
that simulate a younger microenvironment, suggesting that ELF5 may identify both accelerated and
decelerated biological aging. The ELF5 clock may therefore assess changes in the biological aging rates of
breast tissue following treatment with potential breast cancer risk reduction agents. Our goal is to evaluate the
ELF5 clock as a novel breast-specific biomarker for identifying biological responses in intervention trials using
clinically obtainable breast biopsy samples. To address this goal we will (1) vet the ELF5 clock as a breast-
specific biomarker in breast cancer prevention clinical trials. By evaluating retrospectively obtained cDNAs
prepared from de-identified RPFNA samples from breast cancer prevention clinical trials. (2) We will increase
the accuracy of the ELF5 clock by incorporating genes affected by and orthogonal to ELF5 and testing a
multiple correlation strategy. This approach will help in identifying the first breast-specific outcome-associated
biomarkers for treatments with interventions and in developing a tool for evaluating intervention trials for breast
cancer prevention.

Public health relevance
Breast cancer prevention options are limited due to a lack of understanding about the mechanisms that make women susceptible to the disease, making it unclear what constitutes an effective therapeutic target or what should be measured in a prevention trial to determine if the risk of cancer is reduced. Our research on the mechanisms of aging in breast tissue led to the discovery of the ELF5-based biological clock, which accurately estimates breast cancer risk based on the difference between the biological and chronological age of breast tissue. We aim to validate that the ELF5 clock can determine whether various preventive interventions slow or reverse biological aging in breast tissue by analyzing archived samples from a decade's worth of breast cancer prevention clinical trials.